Designer nanodiscs to probe and reprogram membrane biology

Abstract
Life originates from the enfolding of critical cellular activities by water-impermeable membrane structures. This
compartmentalization is vital to maintain the identity and function of all cells and most organelles. However, the
physical barrier of cell membranes also necessitates the development of sophisticated intercellular signaling
pathways, ensuring precise coordination of distinct cellular activities across an organism’s various types of cells
and tissues. In most cases, these signaling events are mediated by the collective interaction of diverse molecules,
ranging from ions, metabolites, and lipids to secreted peptides, proteins, and membrane-embedded protein
complexes. Intrigued by the fascinating precision and function of intercellular signaling in the maintenance of
homeostasis, my laboratory investigates the operating principle of membrane biology underlying the starting
point of cell-cell interactions and communication. Our overarching goal is to establish the connection between
the structural dynamics of membrane protein-lipid interactions and the function of cell physiology. To this end,
we have and will continue to develop the next-generation nanodisc toolbox that can bypass many limitations of
traditional approaches for the characterization of membrane proteins, thereby opening up windows of new
opportunities to access the membrane biochemical space unattainable in previous studies. With these powerful
tools in hand, we seek to advance our understanding of membrane protein-lipid interactions essential for human
health. Specifically, we will focus on interrogating how cell membranes regulate the structure, function and
dynamics of proteins that drive membrane fusion, exosome secretion, and pore formation. Together, the
proposed study will not only generate novel insights into the molecular mechanism of cell-cell interactions and
communication, but also will bring about useful reagents to probe and reprogram fundamental signaling events
at the cell surface.

Public health relevance
Narrative Proper intercellular signaling is essential for homeostasis and centers on the biochemical reactions at the cell surface. Armed with innovative nanotechnology, the proposed study will decipher the molecular underpinnings of cell-cell interactions that are unapproachable using traditional methods, thereby shedding light on new ideas to manipulate membrane biology involved in human health.